EFFECT OF ORAL DOLASETRON MESYLATE ON GASTROINTESTINAL TRANSIT IN HUMANS

The effect of oral dolasitron on segmental GI transit and peptide release will be studied in healthy volunteers and in patients with diarrhea-predominant irritable bowel syndrome.